Project 2VIDA! SARS-CoV-2 Vaccine Intervention Delivery for Adults in Southern California

PROJECT SUMMARY
COVID-19 has disproportionately impacted marginalized people, particularly those from Black
and Latinx communities. Prior to the pandemic, Black and Latinx populations already had higher
rates of chronic conditions such as hypertension, lung disease, heart disease, and diabetes,
which have placed them at much higher risk for negative COVID-19 outcomes compared to
non-Hispanic white populations. While COVID-19 vaccination has been identified as an
important public health measure for addressing the spread and severity of COVID-19, vaccine
hesitancy remains a significant issue. Previous research has linked COVID-19 vaccine
hesitancy among Black and Latinx communities to historical and contemporary experiences of
medical racism; however, the high prevalence of chronic conditions among Black and Latinx
communities complicates questions around trust and vaccine hesitancy. For instance, while
some research has found that individuals with chronic conditions were less hesitant to accept
COVID-19 vaccination than individuals without chronic conditions, other work has suggested
that racialized individuals with chronic conditions remained vaccine hesitant. Previous research
on flu vaccination has also found an association between vaccine hesitancy and previous
experiences of medical mistreatment among individuals with chronic health conditions. There is
some evidence to suggest that racialized individuals with chronic conditions are less likely to
seek medical care due to experiences of medical racism which have increased distrust, which
may be one factor contributing to vaccine hesitancy. While a large body of research has
examined vaccine attitudes among racialized populations and people with chronic conditions,
there has been less research examining actual COVID-19 vaccine outcomes for these
populations. Additionally, there has been a substantial amount of research calling for methods
that can increase marginalized communities’ trust in vaccination through community-based
partnerships and delivery of vaccine information by trusted entities. Project 2VIDA! uses a
community-engaged approach to vaccine promotion and provides a valuable opportunity to
examine vaccine outcomes for racialized individuals with chronic conditions. The proposed
project will seek to better understand the relationship between chronic physical health
conditions, institutional trust, and vaccine outcomes among 2VIDA! participants using
community-based, mixed-methods approaches. This analysis will provide additional context for
vaccine uptake and attitudes among participants as well as expanding the CBPR approach to
explore possibilities for applying findings from Project 2VIDA! to future community-led
interventions. This project will also allow the training of a junior researcher who comes from a
disadvantaged background and is committed to addressing health disparities as well as
advancing diversity and inclusion in research through mentorship and academic service.

Public health relevance
PROJECT NARRATIVE Previous research has linked COVID-19 vaccine hesitancy among Black and Latinx communities to reduced institutional trust due to historical and contemporary experiences of medical racism; however, the high prevalence of chronic conditions among Black and Latinx communities complicates questions around trust and vaccine hesitancy. While some racialized individuals with chronic conditions have indicated less vaccine hesitancy, others have indicated being more hesitant to accept COVID-19 vaccination. The proposed project will seek to better understand the relationship between chronic physical health conditions, institutional trust, and vaccine outcomes among 2VIDA! participants using community-based, mixed-methods approaches.